Natural Killer Cell Regulation of Skin Inflammation

PROJECT SUMMARY
Characterized by chronic skin inflammation, atopic dermatitis (AD) is the most common chronic illness of
childhood and is often a lifelong disease. Numerous immune cell types have been implicated in AD
pathogenesis, including mast cells, basophils, and T helper type 2 (Th2) cells. Recent studies by the Kim Lab
identified group 2 innate lymphoid cells (ILC2s) as critical contributors to development of AD/AD-like disease
through production of the type 2 cytokines IL-4 and IL-13. Indeed, blockade of the IL-4 and IL-13 receptor (IL-
4R) has emerged as the first FDA-approved targeted therapy for moderate-to-severe AD. Despite this major
advance, <40% of AD patients in phase III clinical trials met the primary endpoint in terms of disease
improvement. Development of new AD therapies is hindered by an incomplete understanding of the immune
cell types that regulate the disease beyond type 2 immune cells. There is an urgent need to correct this
knowledge gap to develop effective therapies for AD. Our long-term goal is to target immune regulators of AD
to develop new therapies. The overall objective of our proposal is to identify the immune cell types and effector
mechanisms that regulate AD-like disease. Our central hypothesis is that circulating natural killer (NK) cells are
major regulators of type 2 inflammation in the skin that can be harnessed to treat AD. NK cells have been
implicated in antitumor and antiviral immunity through their production of cytolytic proteins as well as interferon-
gamma (IFN-). Recent studies suggest that NK cells may negatively regulate ILC2s in the lung, but the role of
NK cells in the skin and AD remains unclear. In preliminary studies, we revealed that mouse NK cells critically
suppress skin ILC2 responses in vivo. In humans, we identified that circulating blood NK cells are markedly
deficient in moderate-to-severe AD and increase with disease resolution. The rationale for this proposal is that
once it is understood how NK cells influence AD pathogenesis, these mechanisms can be harnessed to create
effective and novel AD therapies.

Public health relevance
PROJECT NARRATIVE Atopic dermatitis (AD) is the most common chronic illness of childhood and is often a lifelong disease. AD is among the top 50 most prevalent diseases worldwide, has the second highest disability rank of all nonmalignant skin diseases, and is characterized by chronic and relapsing skin inflammation and itch. Despite our increasing understanding of the role type 2 cytokines and group 2 innate lymphoid cells (ILC2s) in AD, development of new AD therapies is hindered by an incomplete understanding of the immune cell types that regulate the disease beyond these cytokines and immune cells. This proposal will interrogate the relevant identity, spatiotemporal dynamics, and effector mechanisms by which natural killer (NK) cells play a previously unrecognized role in limiting type 2 skin inflammation and AD pathogenesis.